The role of the spleen in maintaining immune tolerance to transplanted islets

Project Summary
Transplantation of islets has restored tight glycemic control in patients with type 1 diabetes, but the toxicity of
chronic immunosuppression used to prevent rejection has precluded the application of cell replacement in
diabetes care. By inducing immune tolerance to transplanted islets, we achieved long-term, drug-free islet
transplant survival in nonhuman primates (NHPs). To justify the clinical translation of the protocol, a deep
understanding of the immunobiology that determines maintenance and loss of immune tolerance is required.
Using highly multiplexed immunophenotyping and imaging methods customized for NHPs, our preliminary
studies comparing tissues from tolerant vs. rejecting NHPs led us to hypothesize that the spleen plays a crucial
role in maintaining tolerance to islet transplants in macaques. The retention of allospecific CD4+ T cells, the
abundance of exhausted T cells, their spatial arrangement within the spleen, and the ongoing Treg vs. Teff cell
crosstalk via the Areg-EGFR axis are key contributors to sustained tolerance. We propose two Specific Aims to
address this hypothesis.
AIM 1: To comprehensively profile allospecific Areg+ ST2+ Tregs and immune cell clusters in the spleen testing
the hypothesis that sustained tolerance to islet allografts in NHPs is linked to an abundance of unique Tregs and
Tex cell clusters in the spleen. Splenic Tregs in tolerant NHPs are enriched with elevated Areg and ST2
expression and exhibit an elevated interaction with Teff and Tex cells via Areg-EGFR signaling.
AIM 2: To analyze the spatial interaction of allospecific Areg+ ST2+ Tregs with Teff, Tex, and myeloid cells
clusters in the spleen testing the hypothesis that the retention of allospecific effector cells in special
microdomains of the spleen and their subsequent exhaustion, caused by their proximity to Areg+ ST2+ Tregs in
the spleen, plays a role in the consolidation of tolerance to islet tx
The studies proposed herein will be the first to harness the capabilities of highly multiplexed immuno-phenotyping
of single cells and tissues to investigate the role of Areg-EGFR signaling in splenic Teff cell retention and their
subsequent exhaustion in maintaining nonchimeric transplant tolerance in NHPs. The generated dataset will
represent a valuable resource for the transplant tolerance community, trigger additional studies on the anatomy
of tolerance in the spleen, and promote the clinical translation of tolerance induction to donor- and stem cell-
derived islet cell transplants.

Public health relevance
Project Narrative The proposed work is relevant to public health for two reasons. Firstly, it harnesses the power of advanced proteomics profiling and imaging of immune cells in dissecting the mechanisms by which a recently developed immune tolerance protocol enables transplants to survive without chronic immunosuppression of transplant recipients. Secondly, deeper insights into the mechanisms that consolidate and sustain tolerance may promote the application of cell transplantation in diabetes care.